Genetic Risk Analysis in Ovarian Cancer (GRACE) Administrative Supplement

PROJECT SUMMARY/ABSTRACT
An estimated 1 in 190 women carry a pathogenic variant in BRCA1/2, which is associated with an 46-57% risk
of breast cancer and 20-40% risk of ovarian cancer by age 70. Carriers account for 10% and 15% of breast
and ovarian cancer cases, respectively, and up to 20% of high-grade serous ovarian cancer cases, the most
aggressive subtype. Despite recommendations that all ovarian cancer cases should receive genetic counseling
and testing, irrespective of family history and age at onset, a recent national study indicated that only 10% of
cases underwent genetic testing. This represents a missed opportunity to inform these women and their at-risk
family members about their future cancer risk. The parent study of the proposed supplemental project aims to
address this care gap by applying a traceback testing approach to retrospectively identify women who have a
prior diagnosis of ovarian cancer. Individuals with a prior diagnosis of ovarian cancer who have not received
genetic testing will be offered genetic counseling, testing, and cancer risk assessment. This study will leverage
tumor registries to identify prior cases of ovarian cancer diagnosed within the past 24 years at two managed
care healthcare systems (Kaiser Permanente Northwest and Kaiser Permanente Colorado). The use of
archived pathology samples for germline genetic testing will allow family members of both living and deceased
women to receive familial genetic cancer risk information. We will assess: 1) the feasibility of and barriers
associated with using tumor registries and archived pathology samples for a traceback testing approach, and
2) explore the ethical, privacy, and policy implications associated with genetic testing in deceased patients to
inform familial risk. This parent study will generate evidence on the feasibility of traceback testing using tumor
registries and archived pathology samples which is critically important to guide future implementation of such
programs beyond ovarian cancer. This supplemental project will build upon the aims of the parent study by
using a bioethical research approach to characterize the impact of social determinants on receipt of genetic
risk information at the index ovarian cancer diagnosis. The supplement will leverage the infrastructure of the
parent study and will use the study population identified at Kaiser Permanente Northwest and Kaiser
Permanente Colorado as well as an additional site, Kaiser Permanente Washington. A mixed methods
approach will combine electronic medical record analysis through chart review and abstraction with qualitative
analysis to capture care pathways to characterize the role of social determinants of health at specific points in
these care pathways, such as referral and uptake. The results of this supplement will expand upon the findings
of the parent study to inform future traceback studies by ensuring equitable access to genetic risk information
for all patients with ovarian and other hereditary cancers.

Public health relevance
PROJECT NARRATIVE Uptake of genetic testing for hereditary cancer risk in people with ovarian, fallopian, or peritoneal cancer is low, and represents missed opportunity for potential benefit for relatives. This supplemental project (U01CA244323, Hunter) will examine the relationship between genetic testing at the time of ovarian, fallopian, or peritoneal cancer at the time of diagnosis and social determinants of health in a retrospective sample of people who received care at one of three integrated health systems from 2008-2019. We will use a mixed methods approach of electronic medical record (EMR) analysis, chart review and abstraction, and qualitative analysis.